BLR&D Research Career Scientist Award Application

AIMS: The goal of this application is to competitively renew Dr. Jian-Ying Wang's Senior Research
Career Scientist (SRCS) Award, and to continuously support Dr. Wang's VA research program.
NOMINEE: Dr. Wang has held a position of Senior Research Career Scientist from 2011, and he also holds
the title of Professor in the Departments of Surgery and Pathology at University of Maryland School of
Medicine (UMSOM) at Baltimore. Dr. Wang's research program has been continuously funded by VA-
MERIT Review Awards and multiple NIH-R01 grants for more than twenty-two years. Dr. Wang has had
many seminal research accomplishments throughout his career, and published more than 140 peer-
reviewed original research articles that have created more than 5,000 citations. In addition, Dr. Wang is a
major mentor/sponsor for VA Career Development Awards, and he also acts as a co-investigator in several
currently active VA-sponsored research projects.
RESEARCH: Studies in Dr. Wang's laboratory are to investigate the mechanisms underlying gut mucosal
regeneration and rapid epithelial restitution after acute injury; and to further search for new and more
effective therapies to maintain the intestinal epithelial integrity in patients with critical illness. Defective
regulation of early intestinal mucosal restitution and subsequent disruption of the gut epithelial integrity
occur commonly in various pathological states such as: stress/peptic ulcerations, Crohn's
disease/ulcerative colitis, post-massive surgery, trauma, and sepsis. Since the exact mechanisms
underlying gut mucosal continuous regeneration and rapid mucosal repairs after acute injury are still
obscure; effective therapies to preserve the gut epithelial integrity are limited, especially in patients with
critical surgical illnesses. Dr. Wang's research program is highly focused on the regulation of rapid gut
mucosal repair and homeostasis by Ribonucleic acid ( RNA)-binding proteins (RBPs) and noncoding
RNAs (ncRNAs) in health and surgical diseases. His research program studies stress-related processes
regulated by RBPs and ncRNAs, the post-translational events that affect target gene expression in the
presence or absence of cellular polyamines, and the interplay between RBPs and ncRNAs under
physiological and pathological conditions. Dr. Wang's research employs the state-of-the-art techniques,
including approaches that examine specific messenger (m)RNA/ncRNA or mRNA/RBP interactions as well
as approaches focused on large-scale RNA analyses. His group has also extensively used gain-of-
function transgenic and tissue-specific knockout approaches to generate various genetically modified
animal models. Importantly, Dr. Wang's research projects are directly relevant to surgical patients with
mucosal injury/delayed healing, maladaptation, barrier dysfunction, inflammation, and sepsis. The
overarching goal of Dr. Wang's research program is to elucidate the post-transcriptional processes that
govern gut mucosal regeneration and rapid epithelial restitution, and to create a fundamental base for
development of new therapeutics for gut mucosal injury-related diseases.
IMPACT: Dr. Wang's research program directly addresses an important health issue relevant to the VA
mission, since gut mucosal injury-related diseases such as stress/peptic ulcerations, Crohn's
disease/ulcerative colitis, and gut barrier dysfunction occur commonly in our VA patient population. Dr.
Wang also actively collaborates with a number of investigators in the VA Maryland Health Care System
(VAMHCS) Research Service, and his expertise and academic activity help moving the VAMHCS research
program forward.

Public health relevance
Dr. Jian-Ying Wang is a Senior Research Career Scientist and his research program directly addresses an important health issue relevant to VA health care. Ongoing studies in Wang lab are to fully investigate the mechanism underlying rapid gut mucosal repair after injury, and to search for new therapies to maintain the intestinal epithelial integrity in patients with critical illness. Mucosal injury-related disorders such as: stress/peptic ulcerations, Crohn's disease/ulcerative colitis, trauma, and sepsis occur commonly in our Veteran population, but the effective therapies in clinic are limited. Because improving our understanding of the mechanism involved in mucosa repair is the first step towards therapeutic initiatives, Dr. Wang's research program will strengthen our long-term goal to develop more effective therapeutic approaches for gut mucosal injury-related diseases for our VA patients.